Computational model of targeted drug delivery

PROJECT SUMMARY
Most nanoparticles for drug delivery fail in clinical trials due to insufficiency of animal models, highlighting the
need for additional models to support the development of new nanoparticles. Specifically, there are limited
quantitative methods to aid in the systematic design and development of nanoparticles for drug delivery to
cancerous tumors. The proposed computational models can predict drug delivery to tumors, and we
demonstrate model accuracy in preliminary studies. The goal of this project is to develop computational models
that can simulate drug delivery to tumors in 3-D, incorporating spatial heterogeneities in tumor properties. This
is achieved by employing 3-D imaging studies to derive tumor parameter maps, and then integrating those
maps in the computer model. If successful, the proposed computer models will enable systemic evaluation of
nanoparticles not possible with other experimental methods and may result in more efficient nanoparticle-
based cancer therapies.

Public health relevance
PROJECT NARRATIVE – RELEVANCE TO PUBLIC HEALTH The goal of the proposed project is the development of computational models for design and testing of novel nanoparticles for targeted drug delivery to cancerous tumors. If successful, the proposed computer models will enable the systemic evaluation of nanoparticles not possible with other experimental methods and may result in more efficient nanoparticle-based cancer therapies.